National Practice-Based Research Network Conferences 2023 to 2025

Project Summary
The North American Primary Care Research Group proposes promoting, convening, coordinating,
managing, evaluating, and disseminating the results of the 19th, 20th, and 21st meetings of the Practice-
Based Research Networks (PBRNs) in the summers of 2023, 2024 and 2025. With a projected attendance
of 125, the purpose of the annual two-day conference will be to build on the skills and knowledge of
clinicians, researchers, and community partners in evidence-based research to improve the health of the
U.S. population, healthcare delivery systems, and the quality of primary health care. Along with sharing
translatable insights emanating from research, the conference will link research with clinical practice–
especially primary care practice—by facilitating collaboration among conference attendees, policymakers,
and funders. The Agency for Healthcare Research and Quality (AHRQ) support for the PBRN conferences
help in achieving the goal of improving health care for all Americans, including the priority populations. The
conference allows practitioners to acquire the necessary evidence, interventions, and dissemination to
make better decisions and deliver exceptional, accessible, equitable, affordable, and patient-centered
health care.
NAPCRG has successfully hosted the 2012-2022 PBRN conferences, including 2 virtual conferences due
to COVID-19, and attracted an average of 140 attendees. With input from a Steering Committee (SC)
experienced with PBRNs and prior PBRN conferences, each year, NAPCRG will select a conference
theme and plenary speakers and select papers, workshops, and poster presentations through a call for
abstracts. Conference sessions will address the science of research and operation of PBRNs and provide
for presentation of studies focusing on practice and quality improvement, COVID-19, behavioral health,
patient safety, health information technology/electronic health records, telemedicine, and issues in primary
care practice, and prevention.
NAPCRG will manage all conference logistics—including a call for abstracts, conference
promotion, registration, continuing education accreditation, conference evaluation, and social media
strategy. The proposed conferences will provide skill-building, knowledge transfer, brainstorming future
research agendas, collaboration, and outcomes to a diverse mix of stakeholders.

Public health relevance
Project Narrative The purpose of the proposed national Practice-Based Research Network (PBRN) conferences to be convened annually from 2023 through 2025 is to enhance the skills and knowledge of clinicians and researchers in evidence-based research to improve the health of the U.S. population and the value of health care patient safety. The Agency for Healthcare Research and Quality (AHRQ) conference grant to support these PBRN meetings will assist AHRQ in accomplishing its mission to create evidence that will make health care safer, higher quality, more accessible, equitable and affordable; the conference intends to ensure the produced evidence is summarized, communicated, and applied among clinicians and researchers.